Office of Policy and Intellectual Property

The Office assisted in their continued support and providing oversight over CCRs intellectual property and technology portfolio and supported the infrastructure necessary to ensure continued new and creative collaborations that result in successful technology development and transfer to our industrial partners. The Center for Cancer Research is the most active and successful intramural research portfolio on the NIH Campus consisting of over 280 active clinical trials, new Cooperative Research and Development Agreements with industry, new patents, and new commercial licenses. In addition to the CCRs collaborations with industry, the Center continued to share and transfer CCR technologies with the extramural community by sending several thousand shipments of research materials including new animal models, cell lines, plasmids, vectors, and other research tools to global collaborators. The Centers technologies continue to bring in an increasing amount of royalty income to the institute through licenses. Last year, the net income from CCR royalties increased significantly. CCRs technologies can be found in over 200 licensed products including many successful FDA approved products from CCR laboratories include: AIDS test kit, Fludara, Videx, Hivid, NeuTrexin, Taxol, Vitravene, Velcade, Zevalin, Kepivance, Prezista, and Gardasil. OPIP supported the Centers efforts to ensure that CCR continues to be a leader in biomedical technology successes by being part of an infrastructure that supports collaborations. The Office has continued to provide oversight of CCRs patent expenditures to ensure that funds are appropriately reinvested in new technology development and ensure that research tools are made widely available to the research community. The Office has been actively involved in the CCRs umbrella CRADAs and provides administrative and technical support for several highly successful CRADAs with industry and is actively pursuing additional universal CRADA opportunities. Under these CRADAs, the CCR investigators have gained rapid access to multiple novel pharmaceutical compounds for further basic research and clinical development. In addition to the basic research being conducted with these agents, patients have been treated under multiple protocols. These industrial collaborations will contribute directly to the development of novel clinical compounds with potential for positive impact on public health. One successful project accomplishment from 2014 was that we expanded our collaborations with foundation and grants.